Precision characterization of antimicrobial resistance gene dynamics in bloodstream infection risk after hematopoietic stem cell transplantation

PROJECT SUMMARY
Candidate: Tessa M. Andermann, MD, MPH is a fellowship-trained Infectious Diseases specialist who has
been involved in patient-oriented research throughout her medical training. As an Assistant Professor of
Medicine at UNC, she has specific interests in translational research and is invested in precisely tracking the
development and dissemination of antibiotic resistant organisms in immunocompromised patients in order to
prevent untreatable infections. The specific training objectives for the proposed award include gaining
expertise in: 1) applying next-generation sequencing technologies to characterize antibiotic resistance genes in
gut flora, and 2) designing clinical studies to prevent infections with multidrug-resistant organisms in patients
with cancer. Her expert team of mentors include Drs. Jonathan Juliano, MD, and Anthony Fodor, PhD.
Environment: As one of the nation's premier research institutions, the University of North Carolina provides an
optimal environment for the proposed research. The Division of Infectious Diseases is home to a number of
extremely accomplished basic, clinical, and translational research scientists; within the Division, there is active
work investigating antimicrobial resistance that will provide Dr. Andermann ample guidance and leadership.
The UNC research community's collegial nature is demonstrated in the seamless incorporation of experts in
cancer, the gut microbiome, and microbial genomics with whom Tessa has developed the necessary
relationships to accomplish the proposed research. UNC, in kind, has demonstrated its support of Tessa's
research career by providing the salary support that allowed her to develop this current proposal.
Research: Patients undergoing hematopoietic stem cell transplantation (HCT) whose gut flora are colonized
with antibiotic-resistant bacteria have a higher frequency of bloodstream infections (BSI), and an increased
mortality. Despite the significant burden of antimicrobial resistance (AMR) in this population, knowledge of how
antibiotic-resistant bacteria develop and disseminate in patients is limited. Prior studies in HCT recipients have
not yet investigated the acquisition and transfer of AMR genes within and between gut bacteria that may
contribute to infection. The overarching goal of the proposed research is to assess the impact of gut AMR gene
dynamics on the risk of systemic infections using novel sequencing technologies. The specific aims are to
determine: 1) the timing of AMR gene acquisition relative to transplant, 2) the extent of AMR gene transfer and
dissemination between bacteria in the gut, and 3) the relationship between AMR gene burden and BSI risk
after HCT. To accomplish this, next-generation sequencing will be performed on stool samples from 70 HCT
recipients at two different institutions. We hypothesize that the increased antibiotic resistance gene burden in
the gut resistome after transplant is due primarily to expansion of pre-transplant AMR genes and is associated
with an increased risk of BSI after HCT. We expect that this research will yield a greater understanding of how
antimicrobial resistance develops in gut bacteria that can be used to prevent infections in patients with cancer.

Public health relevance
PROJECT NARRATIVE In patients undergoing hematopoietic stem cell transplantation, systemic infections with antibiotic resistant organisms often result from resident gut bacteria and are associated with an extremely high mortality rate. Despite the significant burden of multidrug-resistant infections, knowledge of how antibiotic resistance is acquired or disseminated in gut bacteria and contributes to the development of systemic infections is limited. This study will use novel next- generation sequencing of the gut flora to understand the antimicrobial resistance gene dynamics that may increase the risk of bloodstream infections in patients with cancer.